PET RADIOTRACERS FOR IMAGING THE DOPAMINE D3 RECEPTOR

DESCRIPTION (provided by applicant): PET imaging studies measuring the change in dopamine D2-class of receptors function have historically used radiotracers that are not capable of discriminating between D2/ and D3 receptors. For example, [11C] raclopride, [18F] fallypride and [11C] PHNO bind with high affinity to dopamine D2 and D3 receptors. Therefore, measurement of D2 receptor binding potential obtained with these radiotracers consists of a composite of D2 and D3 receptor density. A number of studies have provided evidence suggesting that D2 and D3 receptors are regulated in an opposing manner in a variety of CNS disorders. For example, it has been reported that there is a 45% reduction in D3 receptors in the ventral striatum and a 15% increase in D2 receptors the caudate/putamen of postmortem brain samples of Parkinson's Disease. Other studies have shown an increase in D3 receptors and a decrease in D2 receptors in brain samples obtained following chronic exposure to cocaine. Therefore, the development of radiotracers having a high affinity for D3 versus D2 receptors, and vice versa, would be of tremendous interest to the PET imaging and neuroscience research community since it would enable the independent measurement of D2 and D3 receptors in a variety of CNS disorders. Our group is currently funded (through PA-03-112) to develop PET radiotracers having a high affinity and selectivity for D2 versus D3 receptors. The function of the current research project is to develop PET radiotracers selective for the D3 receptor which would complement our ongoing research in the development of D2-selective radiotracers. The ultimate goal of our research effort is to develop a novel strategy for imaging the change in D3 and D2 receptors in a variety of CNS disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: An alteration in the function of the dopamine D3 receptor is thought to play a key role in a variety of pathological conditions including schizophrenia, Parkinson's Disease, Alzheimer's Disease, and drug abuse. However, the precise role of this receptor in these brain disorders is currently not known. The goal of the research described in this grant is to develop novel probes for imaging the D3 receptor in the living human brain with the functional imaging technique Positron Emission Tomography or PET. These probes are expected to provide valuable information on the role of the D3 receptor in disorders of the central nervous system. Public Relevance Statement An alteration in the function of the dopamine D3 receptor is thought to play a key role in a variety of pathological conditions including schizophrenia, Parkinson's Disease, Alzheimer's Disease, and drug abuse. However, the precise role of this receptor in these brain disorders is currently not known. The goal of the research described in this grant is to develop novel probes for imaging the D3 receptor in the living human brain with the functional imaging technique Positron Emission Tomography or PET. These probes are expected to provide valuable information on the role of the D3 receptor in disorders of the central nervous system. __SpecificAimsTextDelimiter__ Specific Aims. The overall goal of this research project is to identify a PET imaging agent that can be used to study the function of the dopamine D3 receptor in the central nervous system (CNS). The D3 receptor is one subtype of the dopamine D2-like class of receptors, which includes the D2, D3 and D4 receptors. Although there have been numerous radiotracers developed for imaging dopamine "D2 receptors" over the past twenty years, all PET radiotracers used for imaging D2 receptor function in vivo have similar affinities for D2 and D3 receptors. A number of recent studies have suggested that dopamine D2 and D3 receptors are regulated differently in a variety of neurological and neuropsychiatric disorders. Therefore, it is necessary to have radiotracers possessing a high affinity and selectivity for D3 versus D2 receptors, and for D2 versus D3 receptors, in order to design PET imaging studies aimed at measuring the difference in regulation of D2 and D3 receptors in a variety of CNS disorders. Our research program is currently funded through the RFA entitled "Development and Application of PET and SPECT Ligands for Brain Imaging Studies" (PA-03-112) to develop radiotracers for imaging dopamine D2 receptors. In the Preliminary Studies section, we describe data describing our in vivo imaging studies with [11C]SV-130, a radiotracer having a high affinity and selectivity for D2 versus D3 receptors. The goal of the research described in the current grant proposal is to prepare an imaging agent having a high affinity and selectivity for D3 versus D2 and D4 receptors to complement our D2 selective imaging agent. The goal of this project is to synthesize and evaluate in vivo a panel of D3 selective imaging agents based on our lead compounds having subnanomolar affinity for the D3 receptor and high selectivity for the D3 versus D2 and D4 receptors. The Specific Aims of this grant are: 1. To complete the synthesis of a panel of D3 -selective ligands which can be labeled with either carbon-11 or fluorine-18. The lead compounds for this study have been synthesized in our lab and have been found to have a subnanomolar affinity for D3 receptors. 2. To measure the affinity of the compounds in Specific Aim #1 for D2, D3 and D4 dopamine receptors, and to determine their intrinsic efficacy at D2 and D3 receptors. Radioligand binding protocols using genetically engineered cells lines will be used to determine the affinity of the proposed compounds at dopamine D2, D3 and D4 receptors. In addition, the affinity of the proposed compounds at sigma receptors and other CNS receptors will also be evaluated. A whole cell adenylyl cyclase assay will be used to determine if the D3 receptor selective compounds possess intrinsic activity at D2-like dopamine receptors. 3. Establish the radiolabeling conditions for preparing the 11C- and 18F-labeled radiotracers; 4. Conduct a series of imaging studies in macaque monkeys in order to identify which radiotracer has the optimal properties for translational imaging studies in humans. Studies will also be conducted in order to determine if there are any radiolabeled metabolites that are capable of crossing the blood-brain barrier and entering the brain 5. Conduct radiation dosimetry and toxicity studies on the optimial D3 selective compound as a preliminary step for obtaining approval for future imaging studies in humans Once completed, this research project, in concert with our ongoing studies on the development of dopamine D2-selective PET radiotracers, is expect to result in a novel paradigm for measuring the change in the D2 : D3 ratio in a variety of CNS and neuropsychiatric disorders.